Administrative Core

Project Summary/Abstract
This Administrative Core will mediate three functions. As part of the first function, it will help
coordinate the Principal Project, the Collaborative Project and the Pilot Project. At a fixed time
on the first Monday of every month the project coordinator and the Investigators and
Coinvestigators of the three projects will meet face-to- face or by Zoom at Massachusetts
General Hospital to chart progress and coordinate studies and sample collection. These
meetings will expand on ongoing regular monthly meetings currently being held. A second goal
of this Core will be to make available tools of Human Immunology research to other
investigators at MGH studying autoimmune disorders other than lgG4-Related Disease
including Next Gen sequencing for repertoire, expertise with investigating immune cells and
tissues in depth, cell storage and profiling techniques. The ACE program coordinator will
regularly inform the broader MGH community of the time and location of the monthly meetings
and an hour will be set aside by the Principal Investigator to meet clinicians and other
investigators at the MGH who seek to interact. These interactions will also facilitate some of the
studies of the Principal Project on the causes of IgG4-related disease. The third goal of this
Core and its coordinator will be to generate a portal for interaction with
other ACEs and to share information on Immune repertoires, microbial community
characteristics and chromatin data with other groups working across the country on
autoimmunity, not necessarily restricted to other ACEs.